Div Supp: Daniela del Rio Pulido CRCNS: Unsupervised Learning of Hippocampal Sequence Dynamic in Sleep

Project Summary:
No changes from original grant R01NS115233

Public health relevance
Project Narrative: No changes from original grant R01NS115233